Improving Corneal Ulcer Outcomes with Unbiased Pathogen and Antimicrobial Resistance Detection

PROJECT SUMMARY/ABSTRACT
Infectious corneal ulcers affect all ages and contribute to significant visual morbidity worldwide. Empiric
treatment with broad spectrum antimicrobials without regard for antimicrobial resistance is presently standard
of care. This is either because pathogen identification with routine microbiological testing is suboptimal or
testing is not done altogether. While empiric treatment is the preferred practice pattern for infectious keratitis
worldwide, this is contrary to the goals and ideals of antimicrobial stewardship. Here, we propose to enhance
the understanding of the pathogenesis of infectious keratitis and antibiotic resistance profiles to improve
diagnostics and therapeutics with the following aims. In the first aim, we will perform worldwide surveillance of
all organisms responsible for infectious keratitis. We expect the spectrum of etiology will vary significantly with
geographic location. In addition, seasonality will affect pathogen profile and disease outcomes. The second
aim will determine the frequency and richness of antimicrobial resistance (AMR) in corneal ulcer pathogens
and correlate those findings with phenotypes. We expect AMR will differ by global location and predict clinical
outcome. Finally, we will define the local immune response in infectious keratitis. We hypothesize that immune
signatures can predict pathogen types and clinical outcome. Corneal opacity secondary to infectious keratitis
remains one of the leading causes of blindness worldwide and we anticipate this research will guide clinicians
on the best management for corneal infection to reduce both the financial and ocular health burden globally.

Public health relevance
PROJECT NARRATIVE (RELEVENCE) Infectious keratitis is a global burden but the epidemiology on causative etiologies and antimicrobial resistance (AMR) patterns worldwide is lacking. This project takes advantage of international collaborations and recent advances in genomic technologies to identify pathogens and provide regional AMR profiles to these infections. The results of this study will decrease AMR proliferation and improve diagnostics and therapeutic approaches for infectious keratitis, thus reducing the burden of corneal blindness in both rich and poor countries.